Application of New Tools for Probing the Roles of Sphingolipids and Cholesterol in Influenza Virus Infection

PROJECT SUMMARY
Influenza A virus (IAV) is a major public health threat that causes 290,000 to 650,000 deaths per year worldwide,
while pandemic strains have caused millions of deaths. Despite the existence of antiviral drugs and vaccines,
IAV still causes high mortality and morbidity due to its ability to rapidly mutate and escape herd immunity.
Identification of the host cell components that promote infection when present at high levels but sustain normal
cell function at lower levels could lead to the development of new types of antiviral therapeutics with universal
strain potency and decreased drug resistance. Sphingolipids and cholesterol are potential targets because IAV
replication and infectivity is correlated with their abundances in the host cell. Why high levels of sphingolipids
and cholesterol seem to promote IAV infection remains a mystery. Likewise, which steps in the virus lifecycle
require these membrane components have not been identified. The research proposed herein will use new
modeling and experimental strategies to investigate the roles of sphingolipids and cholesterol in the IAV lifecycle.
These cutting-edge strategies include molecular dynamic (MD) simulations for modeling IAV fusion peptide
(HAfp) insertion into membranes, and a high-resolution secondary ion mass spectrometry (SIMS) technique for
imaging cholesterol and sphingolipids on and within cells. Three aims that use these techniques are proposed.
In Aim 1 the molecular interactions between different lipid species, cholesterol, and the HAfp will be
characterized by using MD simulations to determine how these cholesterol and sphingolipids affect HAfp
insertion into the endosomal membrane. Completion of this aim will provide understanding of how the HAfp
interacts with distinct membrane lipids, which is a necessary perquisite for elucidating the roles of membrane
composition in IAV fusion during entry. In Aim 2, the sphingolipid and cholesterol abundances at the sites where
the IAV assembles and buds from the host cell plasma membrane will be identified by using a combination of
metabolic rare stable isotope incorporation, immunolabeling, and high-resolution SIMS imaging. This will be a
decisive test of the hypothesis that the influenza A virus assembles and buds from plasma membrane domains
that are enriched with cholesterol and sphingolipids. In Aim 3, high-resolution SIMS depth profiling, an innovative
3D image reconstruction tool developed by sponsor’s lab, and statistical hypothesis tests will be used to visualize
and compare the relative abundances of cholesterol in compartments that contain the influenza virus envelope
protein, hemagglutinin (HA), within IAV-infected and uninfected cells. These studies will test the hypothesis that
cholesterol levels are elevated in the compartments involved in trafficking newly synthesized IAV proteins to the
plasma membrane for assembly into progeny virus particles. Successful completion of these aims may identify
key host cell factors that might be exploited to combat IAV infection.

Public health relevance
PROJECT NARRATIVE Influenza A virus (IAV) is regarded a serious public health threat as it causes 290,000 to 650,000 deaths annually around the world, and pandemic variants have killed millions of people. Due to its ability to rapidly mutate and evade herd immunity, IAV still causes high mortality and morbidity despite the availability of antiviral medications and vaccinations. The main objective of this study is to probe the roles that sphingolipids and cholesterol play during IAV fusion, assembly, and budding from the plasma membrane.